Developmental Research Program

PROJECT SUMMARY
The overall goal of the Leukemia SPORE Developmental Research Program (DRP) is to identify and support
developmental research projects in leukemia for future peer-reviewed funding and/or future independent SPORE
projects. The types of studies to be supported include projects in basic research, clinical research, epidemiologic
studies, and cancer prevention and control research in leukemia. Projects supported under the DRP will expand
the scope of translational research and increase the number of investigators committed to leukemia research.
The DRP will work in tandem with the Career Enhancement Program (CEP) to assist in the development of junior
investigators and in the recruitment and mentoring of Underrepresented in Medicine (URiM) investigators. To
accomplish these goals, the DRP aims to: 1) support developmental research projects in leukemia for future
incorporation as full SPORE projects or application for other major peer-reviewed funding; 2) foster
collaborations between basic and clinical researchers; 3) provide mentoring to junior faculty; and 4) promote the
participation of women and URiM investigators in translational leukemia research and to promote the recruitment
of patients from underrepresented minorities to leukemia clinical trials. New DRP research projects will be
solicited annually, and a total of $370,000 has been committed per year to support CEP and DRP awards,
including $270,000 in matching institutional funds. DRP awards will be for up to $70,000 for 1 year, with a
competitive renewal for a second year of funding allowed. Funds may be used for salary support or laboratory
supplies. The DRP leadership will promote collaborations between basic and clinical researchers through shared
weekly meetings, the annual SPORE retreat, and small group meetings. Where appropriate, mentors will be
identified to work with junior faculty. All DRP awardees will present their research progress to the SPORE
steering committee twice per year.